Circular Dichroism Spectrometer

Project Summary
Texas State University requests a Jasco J-1500 CD spectrometer with accessories for automated
sampling, automated titrations, fluorescence detection, and multi- and micro-sample holders for
the study of protein and nucleic acid structure, dynamics, and ligand interactions. Currently, there
is no such instrument available on campus, as an existing 35-year-old CD instrument that lacks
much functionality has broken and cannot be repaired. The requested CD spectrometer is
essential for the continuation of on-going research and training programs and capacity building in
both research and in education as the university launches a new PhD program in Integrated
Molecular and Biophysical Chemistry. CD is a fundamental tool to which students in this new
program must have access and which has been extensively used by current faculty and students.
Existing research training programs, including R25/T32 Bridges and T34 U-RISE programs, and
educational programs including undergraduate biochemistry majors and minors will benefit from
this new instrument, especially the automation accessories; the U-RISE program emphasizes
laboratory automation training, and a liquid handling robot is already available to assist in arraying
samples for undergraduate laboratory course experiments. The requested J-1500 and
accessories support the long-term objective of the university to attain and maintain designation
as a Research Intensive (R1) institution and to build a strong biomedical research infrastructure
with robust external funding from the NIH. In addition to supporting biomedical research, the J-
1500 will be incorporated into undergraduate biochemistry laboratory courses for majors and
minors. The proposed J-1500 will complement the growing list of university shared
instrumentation acquired to advance biomedical research capabilities on campus, including
recently obtained automated Microcal PEAQ-ITC system, BioTech Neo multi-function plate
reader, and automated Agilent 8900 Triple Quadrupole ICP-MS, as well as recently acquired
instrumentation in individual faculty labs including a Typhoon biomolecular imager, Biosensing
SPR system, and Waters SynaptXS ion mobility mass spectrometer. Oversight for training and
maintenance of the J-1500 will be coordinated by the college-level Shared Research Organization
(SRO), with additional support from a technical staff member from the department of Chemistry
and Biochemistry.

Public health relevance
Project Narrative The study of proteins, DNA and RNA by circular dichroism (CD) spectroscopy provides information on the structure, stability, and interactions of these biomolecules, and these fundamental properties are important in understanding how this biomolecules fold and function and how they may be targeted for the design of new drugs. Building upon existing expertise in CD spectroscopy, Texas State University will purchase a CD spectrometer with advanced capabilities to further research and training at the PhD and MS graduate level as well as education of undergraduate students.